The role of p53 in regulating chaperone-mediated autophagy

ABSTRACT
This proposal aims to define the role of p53 in regulating chaperone-mediate autophagy (CMA) and the
consequences of this regulation on tumorigenesis. p53 holds the distinction of being the most frequently mutated
gene in human tumors. Inactivation of p53 is essential not only for the initiation of a remarkably wide range of
tumors but also for their continued survival and proliferation. Thus, understanding the mechanism by which p53
suppresses tumorigenesis is a central objective in cancer biology. p53 is known to induce apoptosis, cell cycle
arrest, and senescence. However, emerging evidence indicates that these canonical activities may not fully
account for p53-mediated tumor suppression, underscoring the need to identify and characterize additional
cellular processes that are regulated by p53. CMA is a highly selective form of autophagy. Unlike
macroautophagy, which delivers proteins and organelles in bulk to the lysosome for degradation, CMA targets a
subset of cytoplasmic proteins individually. This selectivity permits CMA to regulate intracellular processes. CMA
is demonstrated only in vertebrates, and it might have evolved later during evolution to modulate increasingly
elaborate biological processes. However, both the regulation and functions of CMA remain unclear. We recently
found that CMA governs the balance between self-renewal and differentiation of embryonic stem cells. Our
preliminary results further suggested that p53 may be an important activator for CMA. Through this activation,
p53 inhibits key enzymes in the tricarboxylic acid (TCA) cycle, a central metabolic hub essential for oncogenic
growth. These findings reveal previously unrecognized connections among p53, CMA, and metabolism that
impact tumorigenesis. Our central hypothesis is that p53 is an important regulator of CMA, and p53-mediated
CMA activation and metabolic regulation contribute to tumor suppression. We propose three specific aims: (1)
Elucidate the function of p53 in regulating CMA, (2) Define the molecular mechanisms by which p53 regulates
CMA, and (3) Determine the role of p53-mediated CMA activation and metabolic regulation in tumor suppression.
The proposed studies will reveal a fundamental component of p53 biological function. They will also likely
suggest new targets for cancer therapy.

Public health relevance
PROJECT NARRATIVE p53 is the most frequently mutated gene in human tumors, and its mechanism of action holds the key to understanding essential aspects of tumor suppression. This proposal seeks to define the role of p53 in regulating chaperone-mediated autophagy, a highly selective form of autophagy unique for vertebrates. It will enhance our understanding of p53 biological function and inform the development of effective therapies.